Multi-Tracer PET Tumor Imaging

DESCRIPTION (provided by applicant): One of the greatest strengths of positron emission tomography (PET) is the ability to image any of a number of molecular or physiologic targets using different radiotracers. The clinical utility of PET is well-established for cancer detection and staging. The development of new tracers for imaging metabolism, proliferation, blood flow and numerous other molecular targets offers almost unlimited potential for image- guided personalized medicine. However, much of this potential remains unrealized because current technology permits only one PET tracer to be imaged at a time-multiple scanning sessions need to be scheduled, often on different days, resulting in high costs, image alignment issues, and a long and onerous experience for the patient. We have shown that 2-3 PET tracers can be reliably imaged in a single scan, where imaging results for each tracer are recovered using signal-separation image processing algorithms. These new technologies have now advanced to the point where they are ready to be translated and distributed to end users for widespread research use. This translation will require advances and refinements that make the new imaging techniques easy to use by PET technologists on a routine basis, and moreover the algorithms must be incorporated into software medical devices that meet regulatory and industry requirements. This project will address these issues through continued scientific study closely coupled with software product development through a partnership between the University of Utah and MultiFunctional Imaging (MFI). Scientific advances and algorithm refinements will be performed under documented design and quality control systems, enabling immediate and rapid incorporation of these technologies into a software medical device package (MFI-Oncology). Successful translation of these emerging technologies will be demonstrated by transitioning ongoing clinical research studies at Huntsman Cancer Institute to single-scan multi-tracer imaging. The new MFI-Oncology software will then be widely distributed for research use under end user's IRB-approved protocols. Ultimately, this will enable clinical research studies at multiple institutions to use rapid multi-tracer PET/CT scanning, establishing this new research tool and accumulating data on efficacy for future clinical use.

Public health relevance
PUBLIC HEALTH RELEVANCE: Transformative advances in cancer care will require personalized treatments that have been optimized for individual patients based on imaging results. This project will develop new and improved methods of characterizing tumors using a specially-designed imaging technique called multi-tracer PET/CT, and these techniques will be made available to hospitals throughout the country by distributing them through our industrial partner, MultiFunctional Imaging.